Efficacy Testing of a Culturally Relevant Stigma Intervention in WLWH in Tanzania

ABSTRACT/PROJECT SUMMARY
HIV-related stigma, especially internalized stigma, yields several negative outcomes. According to UNAIDS,
only 62% of Tanzanians living with HIV are virologically suppressed, with gender inequality and HIV-related
stigma acting as major barriers. Despite the negative impact of stigma on HIV outcomes, culturally and
contextually sensitive interventions to mitigate the negative effects of internalized stigma associated
with HIV among women living with HIV (WLWH) are limited and critically needed in Tanzania.
In Tanzania, where 80% of the population lives in rural areas and HIV is the third leading cause of
death, an estimated 810,000 women are living with HIV. 4.5% of Tanzanian adults between the ages of 15
and 49 were living with HIV with the prevalence being higher among women (♀ = 5.5%:♂=3.4%).
Additionally, the prevalence of HIV is highest among women aged 45-49, at 12% (compared with 8.4%
among men of this age). Further, there are disproportionate rates of new infections among young women
in Tanzania (ages 15-24) compared to their male counterparts of the same age. The 2016-2017 Tanzania
Impact Survey identified that women between the ages of 15 and 39 are more than twice as likely to be
living with HIV as their male counterparts. Thus, in recruiting WLWH for this study, we will purposively
recruit based on geography (urban and rural) and ensure that WLWH across the age spectrum are sufficiently
represented.
Labda Siku Moja: Sauti za Wanawake Wanaoishi na VVU (Maybe Someday: Voices of Women Living with
HIV), was identified as a culturally acceptable internalized stigma reduction intervention among
Tanzanian WLWH. In Tanzania, where storytelling is an important part of the oral literature and culture, the
stories of the Labda Siku Moja can help individuals acknowledge and reflect upon new truths in relation to self
and their world producing transformations and insights that endure. Thus, the specific aims for this proposed
study are to:
Aim 1: Assess the feasibility (recruitment and retention metrics; time to administer and completeness of study
instruments; fidelity to intervention; evaluation of study processes) of implementing an internalized stigma
reduction intervention among urban and rural Tanzanian WLWH; and
Aim 2: Test preliminary efficacy and determine effect sizes of an internalized stigma reduction intervention
among urban and rural WLWH (N = 160) using a 2x4 repeated measures randomized controlled trial (2
treatments x 4 time points [baseline, 30 days, 90 days, 180 days]) to determine if the Labda Siku Moja
intervention results in reduced stigma and improved self-esteem and coping self-efficacy (proximal targets).

Public health relevance
Public Health Relevance Statement Stigma is a significant problem for Tanzanian women living with HIV. It has a negative impact on disclosing their HIV status to family members, friends, and sexual partners; postponing or refusing care; seeking healthcare services sought outside one’s community for fear of confidentiality breaches; starting antiretroviral therapy (ART) later than recommended and having troubles taking ART as prescribed; and reducing quality of life. Despite the negative impact of stigma on HIV outcomes, culturally and contextually sensitive interventions to help reduce internalized stigma associated with HIV are limited. This study will test an intervention adapted to the lives and experiences of Tanzanian women living with HIV.